Developing and Evaluating Visual, Auditory, and Tactile and Text Digital Thematic Map Viewer to Provide Blind and Low Vision Individuals Full Access to Thematic Maps for the First Time

Project Abstract
This proposal aims to transform the accessibility of digital thematic maps for the 285 million blind and low
vision (BLI) individuals worldwide. Thematic maps are essential for understanding complex data in various
domains, including climate analysis, electoral processes, and emergency management. However, these maps
are currently inaccessible to BLI individuals, as screen readers often fail to recognize them, and they lack
customization options for low vision users. If an alternative is provided, it is a simple table lacking any
geographic information. This project seeks to commercialize Audiom, an innovative, multimodal, and Large
Language Model (LLM) chat-based digital map viewer. Unlike existing alternatives, Audiom is designed to be
fully compliant with Web Content Accessibility Guidelines (WCAG), enabling BLI individuals to engage fully in
scientific and civic domains.
The project will develop Audiom from a prototype into a fully commercial platform that integrates with
mainstream map tools, laying the groundwork for further research into non-visual and multimodal cartography.
Audiom offers a unique visual experience for low vision users, allowing customization through speech,
textures, and high contrast borders. For non-visual users, Audiom provides an auditory and tactile experience,
enabling navigation through a map with arrow keys or touchscreen swipes, with pitch and speech indicating the
value of features.
The specific aims of this project are threefold: 1) Optimize user performance with the Audiom interface through
user-centered design iterations; 2) Execute community-based comparative usability studies to evaluate
Audiom's effectiveness for BLI and sighted users; and 3) Create, commercialize, and distribute a productionready Software Development Kit (SDK) for accessible digital thematic maps, facilitating easy integration with
existing digital map tools.
By achieving these aims, Audiom will not only make thematic maps accessible to BLI individuals, ensure
compliance with the Americans with Disabilities Act (ADA) and the Rehabilitation Act for government entities,
but also make mainstream the field of non-visual cartography. The commercialization of Audiom will empower
BLI scientists, enhance civic participation, and improve the quality of life for BLI individuals by allowing them to
use digital maps for the first time.

Public health relevance
Project Narrative The proposed research is poised to make a significant contribution to public health by developing Audiom, a digital visual, auditory, tactile, and chat-based map viewer designed to be usable for everyone, including blind and low vision (BLI) individuals. By facilitating BLI individuals' access to essential geographic information in critical areas such as land-cover data, weather, electoral processes, and emergency management, this innovation aims to enhance professional and personal autonomy, civic participation, and quality of life for BLIs. The successful implementation and commercialization of Audiom will not only reduce mortalities related to unusable emergency information, and promote employment in geographic professions, but also contribute to the broader public health goal of reducing illness and disability by ensuring that all individuals, regardless of their blindness, can participate independently and safely in society.